Community Engagement Core

Community Engagement Core (CEC) ABSTRACT
The residents of communities located along the Galveston Bay/Houston Ship Channel (GB/HSC)
region have been shown to have excess risk of exposures to hazardous substances as a result of
various environmental and anthropogenic disasters. In addition to the physical and environmental
factors, many of the residents of these communities are also have social factors that affect their
resilience to disasters. Community engagement can provide a link between the adaptive capacities
of a community and its responses and changes after disasters. An engaged community has greater
resilience and is better able to anticipate future threats and prepare for and recover from adverse
events. The Texas A&M University Superfund Research Center is focused on development,
application, and translation of a comprehensive set of tools and models that will aid in mitigating
the human health consequences of exposures to hazardous substances during environmental
emergency-related contamination events. Accordingly, the Community Engagement Core (CEC)
will develop, test and implement a set of data-driven community engagement projects focused on
fostering local resilience through disaster research response activities. Work in the CEC will be
based on locally-driven needs and grounded in exposure science and multidisciplinary
environmental health research. The CEC is working in close partnership with a large number of
local organizations, planners, other stakeholders, and residents. Specifically, we will pursue four
community engagement aims: 1) Engage community members to determine the factors that can
improve environmental conditions for communities to proactively plan and manage future
environmental risk related to emergency contamination; 2) Develop collaborative, participatorybased
interventions aimed at reducing exposure during environmental emergencies; 3) Develop
and implement citizen science tools for community engagement to reduce the amount and toxicity
of hazardous substances; and 4) Build long-term resilience in the communities by creating capacity
for detection, assessment, and evaluation of the human health concerns from hazardous
substances. The activities proposed under each Aim are aligned with existing, and welldocumented,
stakeholder priorities and build on prior work done with community partners. Further,
the prevention/intervention activities in the CEC specifically support Superfund’s fourth mandate
which includes "basic biological, chemical, and physical methods to reduce the amount and toxicity
of hazardous substances” through the development of evidence-based strategies and an emphasis
on neighborhood-scaled green infrastructure provisions to increase resilience and mitigate hazard
and contamination impacts. The CEC will involve community partners in the entire cycle of
activities, from study design, to data collection, developing resilience strategies, communication of
the findings to all stakeholders, and assistance with implementation.

Public health relevance
Community Engagement Core NARRATIVE The residents of communities located along the Galveston Bay/Houston Ship Channel (GB/HSC) region have excess risk of exposure to acute pollution, emergency chemical spills and incidents, and high-impact natural disasters, such as hurricanes and flooding. Community engagement provides a link between the adaptive capacities of a community and its responses and changes after disruptions, including natural disasters and environmental contamination events. An engaged community has greater resilience and is better able to anticipate future threats and prepare for and recover from adverse events.